Novel anti-neuroinflammatory drug for aneurysmal subarachnoid hemorrhage (aSAH)

ABSTRACT
Nontraumatic (aneurysmal) subarachnoid hemorrhage (aSAH) is one of the most dangerous forms of stroke,
with almost half of victims dying within the first month after diagnosis, and a half of the survivors becoming
severely disabled and incapable of living independently.
This proposal is focused on addressing a common pathophysiological mechanism of neurocognitive outcomes
of aSAH and other acute and chronic brain injuries – dysregulated overproduction of proinflammatory cytokines
in the brain. Despite advances in our understanding of molecular neuroinflammatory mechanisms underlying
adverse neuronal sequelae of acute and chronic brain injuries, approved therapeutics that target this
pathological process are lacking.
ImmunoChem Therapeutics (ICT) proposes to advance MW189, a novel small molecule anti-inflammatory
experimental drug which has already successfully completed phase 1a and phase 1b clinical trials, as a
candidate for a disease-modifying therapy for aSAH. MW189 is a selective suppressor of injury- and disease-
induced proinflammatory cytokine overproduction associated with destructive glia inflammation/synaptic
dysfunction cycles and their long-term neurotoxic effects. This proposed Fast-Track SBIR will deliver a phase
2a trial-ready drug and the corresponding regulatory documentation portfolio for a future pilot trial in aSAH.
Specifically, we will:
1. Extend preclinical efficacy and pharmacodynamic data, and obtain the dosing and drug exposure
information required to support a future phase 2a proof-of-concept clinical study in aSAH patients;
2. Produce and validate a GMP batch of the drug product from the existing cGMP drug substance (API) supply
at a qualified Contract Manufacturing Organization (CMO); and
3. Prepare and submit an amendment to the open MW189 IND for a phase 2a clinical trial in aSAH patients.
The Fast-Track structure will allow us to immediately move from proof of feasibility to SBIR Phase II activities
that flow seamlessly from preparation of the Phase 2 trial-ready drug product to essential regulatory milestones
for a future first-in-patient aSAH trial. Successful execution of the proposed project will position MW189 for
immediate entry into a pilot proof-of-concept phase 2 trial in aSAH patients that will include pharmacokinetics
and a pharmacodynamic arm. The success in that trial will, in turn, make MW189 a first-in-class drug candidate
with a potential to become a novel therapeutic approach to SAH and other acute and chronic neurological
disorders that involve dysregulated neuroinflammation as a driver of disease progression.

Public health relevance
NARRATIVE Nontraumatic (aneurysmal) subarachnoid hemorrhage is a rare and devastating form of stroke, with ~50% fatality rate, which leaves half of survivors with severe disability, incapable of independent living. We developed a small molecule drug candidate, MW189, with potential to improve long-term neurological outcomes in patients with subarachnoid hemorrhage. This SBIR project will facilitate progression to future First-in-Patient clinical trials for MW189 which has already exhibited exceptional safety in recently completed human safety trials.